Efficiency and Safety of Microstimulation Via Different Electrode Materials

Microstimulation has been an invaluable tool for neuroscience researchers to infer functional connections
between brain structures or causal links between structure and behavior. In recent years, therapeutic
microstimulation is gaining interest for the restoration of visual, auditory and somatosensory functions as well
as emerging applications in bioelectronic medicine. Current neural stimulation parameters and safety limits
need to be revised for microelectrodes using more systematic and advanced methodologies. Stimulations via
microelectrodes often require high charge injection for effective modulation of neural tissue without exceeding
the threshold to harm the tissue or the electrodes. Therefore, advanced electrode materials with high charge
injection capability and stability are highly desired. We have developed several types of stimulation materials
based on conducting polymer PEDOT and nanomaterial composites. These materials present different charge
transfer and electrochemical properties as well as biocompatibility, and the effects of these properties on
microstimulation have yet to be comprehensively characterized. This proposal aims to establish new in vitro
and in vivo models to examine the efficiency and safety of stimulation via multiple electrode materials, ranging
from the clinically approved Pt and Iridium Oxide (IrOx) to the emerging PEDOT nanocomposites. Another
challenge with micro-stimulation is its sensitivity to host tissue responses. Implantation of electrodes causes
electrode fouling, progressive neuronal loss and inflammatory gliosis immediately surrounding the implants.
Loss of nearby neurons and axons leads to decreased stimulation efficacy, while electrode fouling and gliosis
increase impedance. Additionally, stimulation itself may further exacerbate host tissue responses if above the
safety limit, which has yet to be defined for microelectrodes and emerging electrode materials. Using in vivo
imaging in fluorescently labeled mice, we will examine the acute and chronic effects of microstimulation on
neurons, microglia and vasculature, while monitoring the electrode material and electrochemical products. We
will use an in vitro multielectrode arrays (MEA) system to study the effects of electrical stimulation on material
and cells, in order to pinpoint the mechanisms of material and tissue damage.
The first aime is to assess the efficiency and safety limit of neural stimulation via different
electrode materials in vivo in acute experiments. For efficiency testing, we will implant the electrodes in the
cortices of GCaMP mice and use 2-photon microscopy to image the calcium signal in order to determine
stimulation threshold and optimum stimulation parameter for each electrode material. as a function of
stimulation parameters. Stimulation threshold and efficiency for different pulse width, interphase period, bias
potential and frequency from each electrode material type will be determined. For safety testing, we will use
Syn-RCaMP/Cx3Cr1-GFP mice to visualize both neuronal and microglia cells and determine the damage
threshold.
The second aim is to examine the effects of stimulation on electrode materials and cultured
cells in vitro. Using a high-throughput in vitro MEA system in which the six microelectrode materials can be
deposited, we will stimulate at safe and unsafe parameters (identified in vivo from Aim 1) for up to 12 weeks.
We will assess electrode material stability and analyze the stimulated media to identify electrochemical and
degradation products. The toxicity of stimulated media will be tested in cultures of neuron, microglia,
endothelial cells and neuron-microglia co-culture at varying doses to determine the detrimental effects of
electrochemical and degradation products on these cells. Finally, we will directly stimulate the cells cultured on
MEAs and characterize cell behavior using quantitative RNA and protein analysis, neural recording/stimulation
and immunohistochemistry.
The third aim is to characterize the chronic safety and stability of microstimulation in vivo from
different electrode materials. Stimulation will be applied one hour per day to microelectrode arrays
chronically implanted in Syn-RCaMP/Cx3Cr1-GFP animals for 12 weeks. In each weekly imaging session, we
will measure the in vivo impedance, CV, charge injection limit, and stimulation threshold. The neuronal
response (activity, health, density), microglia (morphology, coverage and motility) and BBB integrity will be
recorded, and compared over time points between material types, and to the non-stimulated sites. In addition,
we will closely track the electrode health with electrochemical interrogation, imaging and explant analysis.

Public health relevance
Neural stimulation via microelectrodes has been an invaluable tool for understanding brain. Therapeutic microstimulation may restore lost neurological functions and treat diseases. This proposal aims to establish new in vitro and in vivo models to examine the efficiency and safety of stimulation, and test advanced electrode materials to improve microstimulation efficacy and stability.